Chemistry-Biology Interface Predoctoral Training Grant 2024-2029

Project Summary/Abstract
The research and education of trainees in our Chemical Biology Interface (CBI) Program transcends molecular
scales, from the atomistic to the cellular level. We provide training and exposure in techniques to probe, design,
manipulate, or build molecules, biopolymers, biochemicals, macromolecules, and cellular systems, while
maintaining a solid foundation in a specific area of dissertation research. The mission of the program is to provide
mentorship and assistance in the students’ intellectual and career development for their entire time at the
University of Delaware. Our T32 CBI program, spanning 7 departments and 45 faculty trainers, is committed to
expanding the landscape of chemical biology research by providing multiple paths for trainee success. This
starts with a holistic approach to admissions that permits more than one entry point into the program, offering
plasticity that is important for diversity and inclusion. A flexible yet strong curriculum in CORE chemical biology
concepts, delivered using a required Chemical Biology Didactic Course, seamlessly blends lecture, seminar,
and laboratory experiences into 1 or 2 credit modular building blocks, with embedded required Responsible
Conduct of Research (RCR) and Rigor-Reproducibility training. Elective Boot Camps in Chemical Biology
Techniques builds students’ confidence to perform their thesis research. Our curriculum is inclusive, open to all
interested University of Delaware students curious about the chemical biology discipline. Dedicated, selfless
faculty who are essential for the success of the program are supported through genuine mentorship training
experiences such as “Mentoring Grand Rounds” and “Culturally Aware Mentor Training.” This mentoring
community provides the foundation for faculty to shepherd students through their tailored individual development
plans, assuring they utilize “out of laboratory” experiences such as: 1. Research Sabbaticals that serve to
broaden students’ understanding of career options, through dedicated, planned time away from the home
research lab and 2. Teaching Sabbaticals that expose students to modern pedagogy, such as Problem Based
Learning (PBL). Our alumni help fuel these out of field experiences, assuring consistent mentorship. Our
program holistically cares about the entire student as an individual and empowers them by providing unique
elements, such as a “Mindful Return” reentry plans post life-event. Intentional programming has built an
environment where differences are celebrated; the CBI Citizen is one who welcomes and encourages others
regardless of race, culture, sexual background, and/or disability. This model of inclusivity has allowed us to grow
our diversity to 42%, a number that we will strive to maintain as we admit 10 funded CBI Fellows for a funding
period average of 2 years. The University firmly believes that the T32 CBI is critical for its training and
research missions and has consistently committed multi-million dollar match funds to support our
program over its 29-year history, which synergizes with IDeA State COBRE funding mechanisms to directly
infuse excellence into our chemical biology program, training outcomes, and community.

Public health relevance
Project Narrative The research and education of trainees in our Chemical Biology Interface (CBI) Program transcends size scales, from the atomic to the cellular levels. We provide training and exposure in techniques to probe, design, manipulate, or build molecules and complex systems. Funds will be used to implement the proposed plan that has fantastic core Chemical Biology curriculum, Mentor Training for the faculty, and Multiple Paths to make our CBI Program inclusive to everyone.